Validating of Machine Learning-Based EEG Treatment Biomarkers in Depression

SUMMARY/ABSTRACT
The overarching aim of Alto Neuroscience is to advance brain-based biomarkers for psychiatric disorders in
order to both optimize treatment pathways and drive the development of novel pharmacological and non-
pharmacological interventions. Alto does this by developing and applying sophisticated machine learning
computational models to electroencephalography (EEG) data collected at scale in real-world clinical treatment
contexts. Specifically, in this direct-to-phase II SBIR proposal we will refine, and then independently validate,
two EEG-based candidate biomarkers we have identified for stratifying patients with depression in a manner that
both factors biological heterogeneity and informs treatment response. One of our biomarkers was derived in a
“top-down” (i.e. supervised) manner by trying to directly predict treatment outcome, while the other biomarker
presents a complimentary “bottom-up” (i.e. unsupervised) approach that begins by first identifying the most
biologically homogeneous subset of patients and then testing the treatment relevance of the subtyping. Together,
these findings represent very robust individual patient-level treatment-relevant EEG biomarkers, and in both
cases, help define a critically-important objective approach to prospectively identifying and treating treatment-
resistant depressed patients. A successful outcome of the proposed work would yield the first FDA-cleared
biomarkers for stratifying psychiatric conditions. It would also provide a basis for targeted development of
pharmacological and non-pharmacological interventions based on the EEG biomarkers. Both outcomes hold
substantial commercial value and exciting potential for transforming psychiatry.

Public health relevance
PROJECT NARRATIVE The overarching aim of Alto Neuroscience is to advance brain-based biomarkers for psychiatric disorders in order to both optimize treatment pathways and drive the development of novel pharmacological and non- pharmacological interventions. Here we propose to refine, and then independently validate, two EEG-based candidate biomarkers we have identified for stratifying patients with depression in a manner that both factors biological heterogeneity and informs treatment response. A successful outcome of the proposed work would yield the first FDA-cleared biomarkers for stratifying psychiatric conditions. It would also provide a basis for targeted development of pharmacological and non-pharmacological interventions based on the EEG biomarkers.